UTMB Clinical and Translational Science Award

Project Summary Since 2009, the University of Texas Medical Branch at Galveston (UTMB) has worked as a member of the CTSA consortium to accelerate discoveries toward better health. Our Hub addresses scientific and operational barriers to translation at local, regional, and national levels. Our institution is guided by a system-wide approach to quality, and our CTSA, implemented along with a model of rigorous assessment and continuous improvement, has transformed our institution. In conducting these activities, we have identified a need for more efficient, consistent, and impactful communication with NCATS. In support of this objective, we will hire a Research Regulatory Specialist with expertise in quality assurance/quality control, human subjects research regulations, project management, and institutional processes. The Specialist will proactively streamline processes and improve systems, resulting in better service to customers and better translational outcomes. The roles and responsibilities of this new team member will be fully integrated with the activities of our CTSA Hub to facilitate successful administration of the award and associated human subjects research, pilot studies, and scholar projects. Ensuring efficient quality reviews of CTSA-related submissions to NCATS and to the eRA Human Subjects System, as well as effective management of the overall process, will enhance our capacity for advancing the mission of the CTSA consortium.

Public health relevance
Narrative Our CTSA Hub will add a Research Regulatory Specialist to catalyze improvements to the quality and efficiency of our translational programs and to maximize the impact of our programs.